Maternal Obesity affects AMP-Kinase in Muscle Cell Differentiation

DESCRIPTION (provided by applicant): SIGNIFICANCE: 18-35% of pregnant American women are clinically obese, a condition which affects fetal development with long-term consequences for offspring health, including pre-disposition to obesity and type 2 diabetes (T2D). The underlying mechanisms remain poorly defined. RATIONALE: Skeletal muscle (SM) is a key tissue responsive to the oxidation of fatty acids and glucose, and its transition to insulin resistance (IR) precedes the onset of T2D. The fetal stage is crucial for SM development since there is no net increase in the number of SM fibers after birth. Our preliminary studies in fetal SM indicate that maternal obesity (MO) reduced AMP-activated protein kinase (AMPK) activity, and altered fetal SM development by enhancing intramuscular adipogenesis and fibrogenesis, both of which impair SM functions. Myocytes, adipocytes and fibroblasts in fetal SM are derived from mesenchymal stem cells (MSC). Our preliminary studies show that AMPK phosphorylates and enhances 2-catenin mediated signaling, a pathway promoting myogenesis. AMPK also phosphorylates p300, which is expected to impair its function as a co-activator, and p300 is a necessary co-activator for transcription factors regulating adipogenesis and fibrogenesis. AMPK catalytic subunit has two isoforms demonstrating slightly different roles in metabolism. CENTRAL HYPOTHESIS: MO inhibits AMPK, which reduces phosphorylation of 2-catenin and p300 by AMPK, leads to the down-regulation of 2-catenin but enhancement of p300 mediated signaling and a shift from myogenesis to adipogenesis/fibrogenesis during fetal SM development. We have three SPECIFIC AIMS: 1) Evaluate whether 2-catenin is the key mediator linking AMPK to myogenesis in fetal SM; 2) Examine the link between p300 phosphorylation by AMPK and adipogenesis/fibrogenesis in fetal SM; 3) Assess the isoform specific effect of AMPK on myogenesis, adipogenesis and fibrogenesis. APPROACH: We plan to use mouse mesenchymal C3H10T1/2 cells to assess whether p300 and 2-catenin are key mediators between AMPK and MSC differentiation in fetal SM. We will also use the well-established diet-induced obesity mouse model to induce MO and the available AMPK-isoform-specific knockout mice to evaluate the role of AMPK in fetal SM development. Important mediators of selected signaling pathways will be analyzed at both mRNA and protein levels, as well as their location by immunohistochemical staining in fetal SM. OBJECTIVE: The objective is to test the role of AMPK in fetal SM development due to MO and to further explore mechanisms. INNOVATION: We are pioneering studies to define the role of AMPK in fetal SM development. The proposed work is novel, because the effects of AMPK and its associated signaling pathways on fetal SM development due to MO are just becoming to be appreciated. ENVIRONMENT: All methodologies required are already established in our laboratory. The Developmental Biology Group and the Center for the Study of Fetal Programming provide excellent academic environment, and animal and laboratory facilities. IMPACT: Proposed studies will demonstrate AMPK as a key mediator of fetal SM development, which will make it possible to use numerous available anti- diabetic drugs, known activators of AMPK, to prevent impairment of fetal SM development due to MO. Data and knowledge obtained will also allow us to further explore mechanisms regulating fetal SM development due to other maternal physiological stresses. Given the importance of SM for lifelong activities and its close association with obesity and T2D, such intervention will help the increasing number of obese pregnant women in this country to deliver healthy children.

Public health relevance
PUBLIC HEALTH RELEVANCE: The United States is experiencing an obesity epidemic which increasingly involves women of child bearing years. 18-35% of pregnant American women are clinically obese, a condition which affects fetal development with long-term consequences for offspring health, including pre-disposition to obesity and Type 2 diabetes. The underlying mechanisms are poorly defined. The objectives of proposed studies are to explore mechanisms associated with impairment of fetal skeletal muscle development due to maternal obesity. Knowledge obtained will allow us to further explore fetal skeletal muscle development due to maternal obesity and other maternal physiological stresses. Molecular mediators identified are targets for interventions to ensure proper skeletal muscle development in fetuses of obese women. Due to the importance of skeletal muscle for lifelong activities and its close association with obesity and Type 2 diabetes, such intervention will help the increasing number of obese pregnant women in this country to deliver healthy children. AMP-Activated Protein Kinase in Cell Differentiation during Muscle Development Affected by Maternal Obesity Min Du Developmental Biology Group and Center for the Study of Fetal Programming, University of Wyoming, Laramie, WY 82071 The United States is experiencing an obesity epidemic which increasingly involves women of child bearing years. 18-35% of pregnant American women are clinically obese, a condition which affects fetal development with long-term consequences for offspring health, including pre-disposition to obesity and Type 2 diabetes. The underlying mechanisms are poorly defined. The objectives of proposed studies are to explore mechanisms associated with impairment of fetal skeletal muscle development due to maternal obesity. Knowledge obtained will allow us to further explore fetal skeletal muscle development due to maternal obesity and other maternal physiological stresses. Molecular mediators identified are targets for interventions to ensure proper skeletal muscle development in fetuses of obese women. Due to the importance of skeletal muscle for lifelong activities and its close association with obesity and Type 2 diabetes, such intervention will help the increasing number of obese pregnant women in this country to deliver healthy children. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Type 2 diabetes (T2D) and obesity are closely linked metabolic complications, both of which are increasing at alarming rates, especially in teenagers and even children (97). Maternal obesity (MO) represents a special problem that can result in poor fetal development, leading to harmful, persistent effects on offspring, including pre-disposition to obesity and diabetes (6, 37, 78, 84, 87, 112). Mechanisms linking MO to the increased incidence of obesity and T2D in offspring remain poorly defined. Skeletal muscle (SM) is the main peripheral tissue responsive to insulin stimulated uptake of glucose, and composes of about 40 to 50% of the body mass of adults (73); Fetal stage (also includes neonatal stage in mouse SM development due to the mice as an altricial species) is crucial for SM development, because there is no net increase in the muscle fiber number after birth (as an altricial species, in mice, there is an increase of muscle fiber number at the neonatal stage). Fetal and neonatal SM development involves myogenesis, adipogenesis and fibrogenesis (31). Myogenic, adipogenic and fibrogenic cells are derived from mesenchymal stem cells (MSC). Switching the commitment of MSC from myogenesis to adipogenesis will increase intramuscular fat, an event associated with SM IR due to the paracrine effect of intramuscular adipocytes (2, 65, 98), and switching to fibrogenesis leads to impairment of SM function including oxidative capacity (71). In addition, attenuation of myogenesis will reduce the muscle fiber density (131), exerting permanent negative effect on offspring SM strength (8). During aging, a progressive loss of muscle mass occurs accompanied by increased adiposity and fibrosis (13, 71), resulting in the decline in muscle structural integrity and functional capacity (10). Our studies demonstrated that MO induces changes in fetal SM at the early developmental stage, which typically are not observed until later in life, pre-disposing offspring SM to aging characterized by intramuscular adiposity and fibrosis (56, 148). AMP-activated protein kinase (AMPK) is a key player in the development of obesity and T2D (48, 49). Activation of AMPK promotes myogenesis (3) but inhibits adipogenesis (41, 46). Our data show that AMPK inhibition dramatically reduces β-catenin content in cultured cells which is mediated via β-catenin Ser 552 phosphorylation by AMPK (See preliminary data). Because enhancement of Wingless and Int (Wnt)/β-catenin signaling pathway promotes myogenesis, AMPK inhibition due to MO is expected to down-regulate myogenesis. Transforming growth factor β (TGFβ) promotes fibrogenesis via Smad2/Smad4 or Smad3/Smad4 mediated signaling (11, 59). Peroxisome proliferators-activated receptor γ (PPARγ) is a key transcription factor regulating adipogenesis. Both Smads and PPARγ need p300 as a co-activator. p300 is an acetylase which phosphorylates histones and transcription factors to regulate gene expression (38, 111). AMPK phosphorylates p300 at Ser 89 which reduces the affinity of p300 with several examined nuclear receptors, down-regulating targeted gene expression (150). CENTRAL HYPOTHESIS: MO down-regulates AMPK, which attenuates β-catenin mediated signaling but enhances p300 associated signaling, resulting in the shift from myogenesis to adipogenesis/fibrogenesis during fetal SM development. We will pursue three SPECIFIC AIMS: 1) Evaluate whether β-catenin provides the key link between AMPK and myogenesis in fetal SM. We hypothesize that AMPK regulates myogenesis from MSC through phosphorylation of β-catenin at Ser 552. C3H10T1/2 cells are MSC isolated from the mouse embryo (103), which differentiates into myogenic, adipogenic and fibrogenic cells (17, 60, 72, 76, 91, 124) in the same culture condition, ideal for studies to examine cell differentiation. Identified mechanisms will also be tested in vivo using the dietary induced obese mouse model. 2) Examine the link between p300 phosphorylation by AMPK and adipogenesis/fibrogenesis in fetal SM. The working hypothesis is that AMPK promotes adipogenesis and fibrogenesis through phosphorylation of p300. Again, C3HT1/2 cells and dietary induced obese mice will be used. 3) Assess the isoform specific effect of AMPK on myogenesis, adipogenesis and fibrogenesis. AMPK catalytic α subunit has two isoforms, α1 and α2, which appear to have slightly different roles in energy metabolism (62, 137). We hypothesize that AMPK α1 and α2 have slightly different but compensatory roles in the regulation of fetal SM development. Wild-type and AMPK isoform-specific knockout mice and C3HT1/2 cells will be used to study the isoform specific roles of AMPK in myogenesis, adipogenesis and fibrogenesis. The overall objective is to examine the role of AMPK in fetal SM development due to MO and to further explore the underlying mechanisms. Obtaining such knowledge is very important and will have immediate clinical applications, because drugs activating AMPK, such as metformin and numerous other anti-diabetic drugs which are known to activate AMPK, are readily available. Studies described in this proposal will provide crucial knowledge regarding fetal SM development as affected by MO, and facilitate our understanding of the fetal origins of adult diseases. Data obtained will enable us to further explore strategies to prevent poor SM development and to ensure the delivery of healthy children.